Efficient and scalable pangenomes with the move structure

PROJECT SUMMARY
Pangenome references and indexes have been shown to alleviate the reference bias problem. Computer
scientists recently described the novel “move structure,” which supports similar pattern-matching capabil-
ities as the more typical r-index or F M -index structures, but with radically improved locality of reference.
That is, move-structure algorithms access computer memory in a predictable way that minimizes cache
misses, or other kinds of pauses due to data movement. We will adapt the “move structure” to the problem
of pangenome indexing, enabling extremely and consistently fast pangenome queries. This will allow us
to leverage inclusive and bias-avoiding pangenomes in applications where (a) we must keep up with a
sequencer in real-time, e.g. nanopore sequencing, or (b) the index is so big that we must divide it across
many computers, e.g. BLAST-like sequence classiﬁcation.

Public health relevance
PROJECT NARRATIVE Many researchers use DNA sequencing to study disease and biology, and analyzing this data requires sophisticated software capable of piecing together puzzles made of billions of fragments of DNA. Our main strategy for assembling these puzzles, aligning sequencing reads to a reference genome, suffers from the “reference bias” problem, where a lack of inclusiveness in the reference genome used causes it to give incorrect answers. We propose a new index data structure that tackles this problem while allowing for the extremely fast queries needed to keep up with fast DNA sequencers.